Research Training in Pediatric Allergy and Immunology

PROJECT SUMMARY/ABSTRACT
This application is a renewal of our longstanding training grant in Pediatric Allergy and Immunology. This training
program is designed to provide physicians and qualified Ph.D. candidates with the skill set necessary to
become successful physician scientists in the field of Allergy and Immunology. It is fully expected that all
trainees will go on to pursue full-time careers in academic medicine and the training is specifically designed to
accomplish that goal. Each trainee spends the vast majority of his/her time in direct laboratory, clinical, and/or
translational research, supplemented with formal course work and seminars, while fulfilling required clinical
training responsibilities. The Program Director, Dr. Robert Wood, actively oversees the training program for
each trainee and a single faculty member acts as the primary preceptor for each trainee. In addition, each
trainee's program is guided by a Scholarly Oversight Committee, charged with overall guidance regarding
his/her research, helping to select those courses and / or degrees which will be most important to the trainee's
development, and ensuring that the trainee's other activities are appropriately limited so that success in
research training – the primary mission of the training program – is ensured. As will be detailed through this
application, the program has enjoyed great success in accomplishing its mission and is currently
exceedingly well positioned to continue at that same high level of achievement. The 24 faculty included
in this training grant include of 16 professors, 4 associate professors, and 4 assistant professors. These
faculty bring a wide range of expertise as well as a wealth of funding. In addition to the five core faculty with
primary appointments in our division, we have forged close relationships with other faculty from across the
Johns Hopkins community, 19 of whom are included in this application. These include members of the
divisions of Pulmonary Medicine in the Department of Pediatrics, the divisions of Clinical Immunology,
Pharmacology, and Pulmonary Medicine in the Department of Medicine, the divisions of Environmental Health
Sciences, Biostatistics, Child Health and Development, Health Policy, and Epidemiology in the Johns Hopkins
Bloomberg School of Public Health, and the Institute of Genetic Medicine. Each of these faculty members is
an active collaborator with one or more members of our division and each has actively participated in the
training of our fellows and junior faculty, demonstrating an enormous commitment to our training program and,
most importantly, providing a wide and dynamic range of research opportunities. We are seeking funding for 3
trainees per year, with the intent being to enroll one new trainee per year where M.D. candidates are accepted
into a three-year, research intensive fellowship. However, we will also leverage each funded position to
maximize research time, so that some trainees will be funded by other sources for any years with a heavier
clinical focus, thereby maximizing T32 resources to support other trainees with protected research time.

Public health relevance
Project Narrative Allergic and immunologic disorders continue to rise in prevalence and currently account for many of the most common and important diseases affecting infants and children. The need for cutting edge basic, translational, and clinical research in pediatric allergy and immunology is therefore greater than ever, although exceedingly few programs are equipped to provide the training needed to conduct this research. Support for programs like ours, that are not only equipped to provide the best possible training but also have a documented record of success in producing the leaders in pediatric allergy and immunology, is therefore more important than ever.